Metabolic Responses to an Oral Mixed Meal Tolerance Test: Intra-individual changes, correlates, and prognostic significance

PROJECT SUMMARY/ABSTRACT
Cardiometabolic disease (CMD), including diabetes, obesity, and cardiovascular disease (CVD), represents an
enormous public health burden. Although a large number of clinical risk factors and molecular biomarkers are
known to contribute to CMD risk at the population level, individual-level risk prediction remains challenging and
there is an unmet need to identify individuals during earlier, and thus more modifiable, subclinical stages in the
development of CMD. The systemic response to discrete physiologic perturbations (or ‘stresses’) can unmask
abnormal metabolic and homeostatic functions that are not apparent in a resting state. Therefore, we propose
to systematically assess responses to an oral mixed meal tolerance test (MMTT), which represents a
standardized, reproducible, and physiologic metabolic challenge. Preservation of energy balance and efficient
storage of fuel substrates after a meal requires a coordinated multi-organ systemic response. Subclinical organ
system dysfunction can alter post-meal metabolism leading to distinct circulating metabolic signatures. In this
application, we will capture integrated responses to a MMTT by assaying dynamic changes (from fasting to 2
hours post-prandial) in ≈600 circulating small molecules providing broad coverage of the human metabolome.
Fasting metabolite profiles are associated with key CMD risk factors and events, but how intra-individual
changes in these metabolites after a meal reflect subtle differences in metabolic health is largely unknown.
Accordingly, we hypothesize that the metabolic response to a MMTT can reveal cardiometabolic dysfunction
that is not evident by fasting blood measures. To test this hypothesis, we will characterize MMTT responses in
3037 Framingham Heart Study (FHS) participants at the fourth exam of the Generation 3/ Omni 2 cohorts. Our
specific aims are: (1) to characterize metabolomic responses to a MMTT and their relations to CM traits and
insulin resistance; (2) to relate post-MMTT metabolite responses (and baseline levels of metabolites with large
post-meal excursions) to cardiometabolic and CVD and outcomes in the FHS and in the Coronary Artery Risk
Development in Young Adults (CARDIA) Study; (3) to assess molecular determinants of post-MMTT metabolite
responses including genetic variation, antecedent metabolite trajectories, and the gut microbiome composition.
Our application will systematically evaluate metabolic responses to a MMTT in the community with the goals of
identifying abnormal responses not accessible by standard fasting measures that provide innovative insights
regarding future CMD risk and of discovering novel biological pathways that may be amenable to drug
modulation. Our study team includes experts in the fields of epidemiology, metabolomics, diabetes, high-
dimensional molecular assays and data analysis, and bioinformatics. By systematically assessing metabolic
responses to a standardized oral meal in community-dwelling individuals with varying cardiovascular risk
profiles, we will provide an important resource to the scientific community.

Public health relevance
PROJECT NARRATIVE Given the increasing burden of obesity, diabetes, and heart disease in the community, new methods are necessary to identify individuals who are at greatest risk of developing these conditions. For this purpose, we propose to measure small molecules in the blood (that reflect body metabolism) before and after a standardized meal challenge in a large community-based sample. Our results will clarify how intake of meals results in dissimilar patterns of small molecules in blood in different people and how these distinctive patterns may identify novel markers of heart disease and diabetes risk that may not be apparent with blood measures obtained in a fasting state.